Colonoscopy augmentation with Fluorescence Lifetime Imaging (FLIm): colorectal cancer detection in humans

PROJECT SUMMARY
Colorectal cancer (CRC) is the second leading cause of cancer-related mortality globally, with current screening
techniques, such as colonoscopy, demonstrating limitations in accurately detecting subtle structural
abnormalities and biochemical changes in colorectal lesions. These limitations contribute to missed diagnoses
and incomplete resections, which account for over 85% of post-colonoscopy CRC cases. This project aims to
address these challenges by integrating label-free fluorescence lifetime imaging (FLIm) into standard
colonoscopy procedures to enhance the detection and characterization of colorectal lesions in real-time.
FLIm offers a novel approach to providing detailed biochemical information by capturing autofluorescence
signals that reflect changes in tissue composition, metabolism, and structure. We hypothesize that FLIm can
capture biochemical changes associated with inflammation and carcinogenesis, facilitating better staging of
colorectal lesions. The proposed research is based on three specific aims and will first build a comprehensive
database of in vivo FLIm signatures from colorectal lesions in 200 patients undergoing routine colonoscopy,
correlating these signatures with histopathological findings to establish robust markers for lesion detection and
classification (Aim 1). We will then develop advanced, user-friendly algorithms to enable rapid, real-time analysis
and visualization of FLIm data during colonoscopy, making the system practical for clinical use (Aim 2). Finally,
we will evaluate FLIm's sensitivity and specificity in identifying and staging a range of colorectal lesions, from
benign polyps to malignant tumors, using machine learning techniques (Aim 3).
By integrating FLIm into colonoscopy, this project seeks to overcome the current limitations of endoscopic
imaging, providing clinicians with real-time biochemical insights that improve lesion detection, diagnosis, and
decision-making. The expected outcomes include a fully developed FLIm-colonoscopy system that can
significantly enhance CRC screening accuracy and early-stage diagnosis. The long-term impact of this work will
be the reduction of CRC incidence and mortality through improved screening technologies and better clinical
management of colorectal diseases.

Public health relevance
PROJECT NARRATIVE Colorectal cancer (CRC) is a significant global health burden, and current colonoscopy methods are limited in detecting subtle structural and biochemical changes in lesions, leading to missed diagnoses. This project aims to integrate label-free fluorescence lifetime imaging (FLIm) into colonoscopy to enhance lesion phenotyping by providing real-time biochemical information. By creating a comprehensive database of FLIm signatures, developing advanced analysis algorithms, and evaluating FLIm's diagnostic accuracy, this research seeks to improve early detection and diagnosis of CRC, ultimately advancing patient care and outcomes.